GASTROINTESTINAL LYMPHATIC TISSUE SAMPLING TO DETERMINE ACTIVE HIV1 REPLICATE

The gastrointestinal tract is considered the largest lymphoid organ in the body based on physical dimensions. Previous investigators have demonstrated that HIV-1 infected cells are more numerous in the lymphoid tissue than in peripheral blood. We hypothesize that the Gut Associated Lymphoid Tissue (GALT) may serve as a resevoir for HIV-1 infection and may provide a sensitive method by which to follow the therapeutic response to antiretroviral medication in patients with HIV-1 infection. This study will provide lymphatic tissue for HIV-1 quantitation and permit evaluation of the cellular changes in the lymphatic tissue in response to treatment with antiretroviral medication.